Development of a Vaccine for HIVAIDS: Humoral Immunity

We have shown that immunization with live, replication-competent Ad-HIV or Ad-SIV envelope recombinant vaccines not only elicits cellular immunity, but also primes strong antibody responses that develop following administration of booster immunizations with envelope protein. These antibodies display a variety of functional activities. The most desirable for an HIV/AIDS vaccine is neutralizing activity that is able to prevent infection following exposure to the virus. We have shown in pre-clinical studies that our prime/boost vaccine approach results in neutralizing antibodies that can confer apparent sterilizing immunity following challenge of rhesus macaques with an HIV/SIV chimeric SHIV virus. HIV/SIV infection is initially manifested as small foci of infected cells. Within 2 to 6 days, virus spreads from these foci to draining lymph nodes, subsequently leading to systemic infection. In addition to neutralization, our vaccine approach elicits antibodies that possess other functional activities that although not able to block infection, may contribute to control of the initial viral burden by limiting the spread of virus from these foci of infection. Such activities include antibody dependent cellular cytotoxicity (ADCC), and antibody dependent cell-mediated viral inhibition (ADCVI). Our recent studies, again in the rhesus macaque model, demonstrate that these non-neutralizing antibody activities are correlated with lower viral burdens. Since HIV is transmitted mainly at rectal/genital mucosal sites, a key goal of HIV vaccine development is to elicit mucosal immunity. The Ad-recombinant prime/protein boost strategy induces antibodies in mucosal secretions which we have shown can inhibit transcytosis of SIV across an epithelial cell barrier, suggesting another mechanism which may contribute to protection. In fact, we have recently shown that transcytosis inhibition by such vaccine-induced mucosal antibodies is also correlated with reduced chronic viremia following challenge, suggesting this activity may help prevent cell-to-cell spread of the virus. In comprehensive studies aimed at fully characterizing vaccine-elicited antibodies, we have examined their avidity to determine whether this characteristic plays a role in protective efficacy. We have discovered that antibody avidity is correlated with functional antibody activities, indicating that antibody maturation is an important property of vaccine-elicited antibodies. Further, we have developed methodology to investigate memory B cells. The ability of vaccines to elicit long lasting memory B cells is a critical property if immunization is to provide long-lasting, and potentially life-long protection. We have shown that our repliction-competent Ad-recombinant prime/envelope boost approach elicits memory B cells, correlated not only with antibody-dependent cellular cytotoxicity, antibody-dependent cell-mediated viral inhibition, and transcytosis inhibition, but also with better protection. Elite-controller macaques initially vaccinated more than 8 years ago, were shown to control plasma viremia to undetectable levels by potent, multifunctional antibydy responses, as well as cellular immunity. The role of humoral immunity in this elite control was substantiated by microarray analysis showing expression of immunoglobulin genes in the intestine following a heterologous viral challenge. Overall, our recent studies continue to demonstrate that our vaccine strategy induces long-lasting, high-titered antibodies with a spectrum of activities both in serum and mucosal secretions, which together contribute to strong protection against viral challenge in non-human primate models. These findings have advanced the approach toward phase I clinical trials.